Advancing Cancer Control for Health and Value (ACCHV)

Many countries have introduced policies and programs to advance cervical cancer prevention, but burden remains high. This project aims to (A) collect primary (qualitative and quantitative) and secondary (quantitative) data about cervical cancer prevention at multiple levels; and use these data in (B) multi-level modeling to identify what is most strongly associated with cervical cancer prevention, and (C) agent-based models to explore increasing population-level coverage of recommended cervical cancer prevention tools. Kenya and Malawi were selected for this study due to their high cervical cancer burden, and different approaches to implementing their national cervical cancer prevention and control programs. To our knowledge, this would be the first large-scale study on this topic. The project will leverage research partnerships between NYU and highly experienced research partners.

Public health relevance
Cervical cancer burden represents a major burden of disease globally. Although many countries have national cervical cancer prevention and control programs, little is known about how these are being implemented and received. Through mixed methods research to collect and analyze data on multi-level factors associated with cervical cancer prevention, this study seeks to identify how to achieve improvements in cancer control.